A 26 WEEK RANDOMIZED, DOUBLE BLIND, MULTICENTER TRIAL OF BRL 49653C

This study is to evaluate the efficacy of BRL 49653C in reducing hyperglycemia when administered to NIDDM patients, as assessed by a reduction in HbA1c after 26 weeks of repetitive, oral dosing, at a dose of 4 mg or 8 mg once day in comparison to placebo.